MEMBRANE RECONSTITUTION AND FUSION

The research goals are directed towards an understanding of mechanisms of membrane fusion mediated by viral spike glycoproteins. We are specifically studying the mode of action of the G protein of Vesicular Stomatitis Virus (VSV) and the HN and F proteins of Sendai Virus. Specific topics include: i) development of fluorescent methods to study kinetics and extent of adhesion and fusion using intact and reconstituted virions, and liposomes and cells as targets; ii) development of methods to analyze reconstitution of viral spike glycoproteins; iii) analysis of factors which determine approach of virus to target (electrostatics, steric constraints); iv) analysis of factors which promote membrane deformation and destabilization (liposome size, lipid composition, osmotic forces); v) Examination of possible effects of pH-gradient or membrane potential on fusion rates; vi) analysis of the role of cooperativity of viral glycoproteins in mediating fusion; vii) Examination of the disposition of the fusion protein after the fusion event; viii) Identification of possible fusion intermediates; ix) Development of methods to study fusion activity of mutants of viral proteins using cloned viral membrane protein sequences expressed in transfected cells; x) Structural studies of viral proteins; xi) Development of methods for using reconstituted viral envelopes as vehicles for specific delivery of materials into cells.